Mechanisms facilitating microbial co-inheritance

PROJECT SUMMARY
Eukaryotic cells are home to a diversity of organelles, symbionts, and pathogens that are often co-inherited
across cell lineages and from parent to progeny. Across humans, animal models, and arthropod vectors of
pathogens, intracellular microbial community dynamics are associated with numerous effects on host
physiology that ultimately result in disease. These include mitochondrial diseases, exacerbated clinical
symptoms of co-acquired pathogens, altered transmission dynamics of vector-borne pathogens, interactive
effects on host immunity and metabolism, and even dysbiosis of the host gut microbiome. There is great
interest in defining the factors that promote or inhibit co-inheritance of intracellular bacteria due to the
combination of their direct and indirect effects on animal health and for their potential use as anti-pathogen
agents. We propose to use a suite of insect models to investigate the factors that regulate co-inheritance of
intracellular microbes with a focus on Wolbachia: alpha-proteobacteria, related to the intracellular human
pathogens Anaplasma, Rickettsia, and Ehrlichia. Unlike their close relatives, Wolbachia inhabit the cells of
arthropods and nematodes and manipulate host biology to facilitate vertical transmission via the maternal
germline. The consequences of Wolbachia infections are diverse and include reproductive isolation between
host populations, matriline sweeps, protection against secondary infections with pathogens, and even host
speciation. Furthermore, some arthropods harbor multiple, stably co-transmitted strains of Wolbachia that must
compete for host resources and space in the germline. Importantly, these Wolbachia-mediated phenotypes are
currently being applied to manage vector-borne pathogens, and, there is significant applied interest in
leveraging coinfections of Wolbachia to fine-tune and expand management programs. Given the applied
interest in Wolbachia and its broad success as an endosymbiont of ecdysozoans, they are an attractive model
for understanding the mechanisms of coinfection. Our long-term goals are to define the mechanisms behind
host-microbe and microbe-microbe interactions that ultimately determine inheritance and evolution of these
associations. This proposal derives from our published work and preliminary data that has given us techniques
to manipulate and track intracellular infections, our ability to perturb a naturally stable coinfection, and our
discovery that intra-organismal niche partitioning plays a key role in coinfection stability. We propose to use a
combination of techniques including high throughput analysis of transcriptomes, multiplexing spectral
microscopy, and molecular and cell biology approaches to accomplish the following Specific Aims: (1) Define
factors that facilitate co-establishment of intracellular microbes, (2) Identify features of stable coinfections that
facilitate evolutionary stability. We anticipate this work will identify conserved mechanisms that regulate
intracellular infections, as well as provide foundational knowledge to support the development of therapeutic
strategies focused on intracellular microbes.

Public health relevance
Project Narrative Intracellular microbes such as pathogens, symbionts, and mitochondria have profound impacts on animal physiology and health, but there is limited functional understanding of what factors regulate interaction and inheritance of the intracellular community. This research will use insect models combined with a suite of molecular tools and multiplex fluorescent microscopy to define how intracellular infections establish and evolve stable associations with other co-inherited microbes. The simplicity and tractability of this model will inform our understanding of intracellular communities in far more complex systems, particularly those that impact human health.